EMOTION RELATED LEARNING &AFFECTIVE EXPRESSION IDENTIFICATION IN CHILDREN

The characterization of emotional learning and face and voice expression identification will be studied through performances of children and adolescents with autism and learning disability on measures of these variables. Performances of the groups on two measures of emotional learning (reversal learning and extinction) and two measures of expression identification (face expression and voice expression) will be compared.